TRIAL TO EVALUATE THE SAFETY OF AZT IN PREGNANT HIV INFECTED WOMEN

The purpose of this study is to determine the efficacy, safety and tolerance of oral AZT in pregnant HIV infected women and their infants.